The role of NPRL2 loss in focal cortical dysplasia

Project Summary
Malformations of brain development are a common cause of neurological disorders in children. The most
common of these neurodevelopmental disorders is the large group of malformations of cortical development
(MCD) characterized by disruption of the structure of the cerebral cortex (e.g., enhanced cell size, altered
lamination). Somatic mutations have been identified in regulatory genes of the PI3K-AKT3-mTOR (mTOR)
pathway in the brain tissue of patients with these MCD collectively termed ‘mTORopathies.’ Focal cortical
dysplasia is a particularly challenging mTORopathy due to the presence of highly epileptogenic lesions within
the cortex that are often resistant to medication and/or difficult to resect. The most common genetic variants
causing FCD are found in genes that encode protein subunits forming the GATOR1 complex: DEPDC5, NPRL2,
and NPRL3- a negative regulator of mTOR signaling. Many studies have linked variants in DEPDC5 and NPRL3
to mTOR pathway hyperactivation, MCD, and seizures, but there few studies functionally validating or modeling
variants in NPRL2 and, currently, mTOR inhibitors are not used to treat epilepsy in these patients. This project
seeks to investigate the effects of Nprl2 loss in vitro and in vivo and to identify the mTOR-dependent
transcriptomic changes that occur as a result of Nprl2 KO. The results of this proposal stand to provide a deep
functional and transcriptomic understanding of NPRL2 variant associated phenotypes, provide pre-clinical
support for the use of mTOR inhibitors in effected individuals, and identify novel therapeutic targets downstream
of mTOR that may provide precision therapy options in the future.

Public health relevance
Project Narrative Focal cortical dysplasia (FCD) is a common cortical malformation associated with medically refractory epilepsy and most frequently caused by variants in subunits of the GATOR1 complex (a negative regulator of mTOR): DEPDC5, NPRL3, and NPRL2. The least studied of these variants is NPRL2 and in this proposal we aim to define the pathophysiological consequences of Nprl2 KO in vivo and in vitro. Using a mouse model of FCD we will define the morphological and functional changes that occur due to Nprl2 KO-induced mTOR pathway hyperactivation as well as investigate the transcriptomic changes that occur downstream of mTORC1 that may produce MCD and seizures.